Angiotensin-(1-7) engages hypothalamic arcuate-paraventricular nucleus inhibitory pathways to lower blood pressure

PROJECT SUMMARY
Obesity is a global epidemic that greatly increases the risk for developing hypertension and cardiovascular
disease. The molecular mechanisms connecting hypertension with obesity are poorly understood, however,
and optimal treatment strategies are unclear as some antihypertensive drugs elicit adverse metabolic side
effects. This illustrates the critical need to identify new therapeutic targets with a positive metabolic profile for
treatment of obesity hypertension. We propose that angiotensin (Ang)-(1-7), a protective hormone of the renin-
angiotensin system, provides this ideal target. Ang-(1-7) binds mas receptors (masR) to lower blood pressure
and improve metabolic function in obese and hypertensive rodents; but the mechanisms involved are
unknown. Our preliminary data show that Ang-(1-7) depressor effects require activation of masR within the
arcuate nucleus of the hypothalamus (ARC). More specifically, we show that Ang-(1-7) masR are highly
localized to proopiomelanocortin (POMC)-containing neurons that release the inhibitory neurotransmitter
GABA. Activation of GABAergic POMC neurons by Ang-(1-7) could lower blood pressure by inhibiting
downstream melanocortin-4 receptor (MC4R) signaling in the hypothalamic paraventricular nucleus (PVN), but
this has not been explored. This proposal will test the central hypothesis that Ang-(1-7) stimulates ARC POMC
neurons to enhance GABAergic neurotransmission onto PVN neurons to lower blood pressure. Aim 1 will
determine if POMC masR are required for Ang-(1-7) to inhibit PVN neuronal activity and lower blood pressure.
To test this, we will employ a novel transgenic mouse model to determine if deletion of masR from POMC
neurons prevents the ability of Ang-(1-7) to enhance GABAergic activity in the PVN and lower blood pressure
under normal conditions and in the context of high fat diet-induced obesity hypertension. Aim 2 will determine if
high fat diet decreases, and Ang-(1-7) treatment restores, GABAergic transmission onto MC4R-expressing
PVN neurons. To test this, we will employ MC4R-GFP mice to determine if: high fat diet decreases inhibitory
neurotransmission in MC4R-expressing PVN neurons, Ang-(1-7) treatment reverses these effects, and
changes in inhibitory neurotransmission in MC4R-PVN neurons correlate with blood pressure. The findings
from this proposal will provide new insight into the neural mechanisms by which Ang-(1-7) lowers blood
pressure as well as the potential for therapeutic targeting of Ang-(1-7) in obesity hypertension. Importantly, this
proposal will logically build upon the PI’s background in molecular neuroscience and allow her to develop a
new skillset in integrated molecular and whole animal physiological and pharmacological methods to assess
neural mechanisms engaged by Ang-(1-7) for cardiovascular regulation. The PI will receive strong mentorship
and a research framework to establish an independent and novel area of research to help meet her long-term
career goal of becoming an independent investigator at an academic research institution where she can
conduct collaborative and clinically relevant cardiovascular neuroscience research.

Public health relevance
PROJECT NARRATIVE Obesity is a worldwide health problem that increases the risk for hypertension and cardiovascular disease; however, the molecular mechanisms connecting obesity with hypertension and optimal therapies to lower blood pressure in this disease remain unclear. This proposal will test the hypothesis that angiotensin-(1-7), a protective hormone of the renin-angiotensin system, engages inhibitory signaling pathways within the hypothalamus of the brain to lower blood pressure in obesity hypertension using innovative transgenic mouse models combined with gold standard physiological, pharmacological and molecular approaches. The findings from this proposal will provide new insight into how angiotensin-(1-7) interacts with the brain to lower blood pressure as well as the potential for targeting Ang-(1-7) as a new treatment for obesity hypertension.